Core 1: Planning and Evaluation

The goals of the Planning and Evaluation Core (PEC) are to monitor, evaluate, and assess the progress of our U54 Partnership in meeting its milestones, objectives, and goals. The PEC supports our University of California, Riverside (UCR)–City of Hope Comprehensive Cancer Center (CoHCCC) U54 Partnership’s goals of capacity-building, education, and training. Together in this U54, UCR and CoHCCC aim to develop the collaborations, translational resources, and training programs to enhance cancer research and drug development throughout the entire drug development pipeline. To achieve our PEC’s goals, we are guided by the Internal Advisory Board (IAB), External Advisory Board (EAB), and Community Advisory Board (CAB). Through the activities and oversight of our EAB, our advisory boards will 1) conduct evaluation, tracking, and reporting of the progress of projects and cores and 2) provide focused feedback to program U54 leadership and investigators. As in our P20 planning grant, the U54 PEC will work with the IAB to provide a structured and rigorous review process to select new Full and Pilot projects and Mini-Pilots for the Capacity Core. Aim 1: Planning: The PEC will provide effective planning and structured partnership activities. Aim 2. Prioritization and implementation: Conduct a rigorous review and prioritize existing and proposed new U54 scientific projects. Aim 3. Track, monitor, evaluate progress towards U54 Partnership goals. Aim 4: External independent program evaluation.